REPOSITORY PULL FOR B WELL MOM MICROBIOME ANALYSIS

The B Well Mom Study aims to increase understanding of factors that predict poor asthma control during pregnancy as well as to add to our knowledge of the basic immunology of pregnancy. There is a growing literature linking gut microbiome to asthma. In the general population, there is a greater microbial diversity among women with no asthma than those with asthma, with a greater abundance of anti-inflammatory taxa and conversely, a greater abundance of pro-inflammatory bacteria among women with asthma. Gut microbiotas are also involved in the production of immunoglobulin E (IgE) and are associated with lung functions such as forced expiratory volume (FEV). This task order is to utilize the BWM microbiome specimens to further explore the underlying physiology related to asthma and pregnancy. Gut microbial count data from approximately 2100 samples shall be obtained using 16S ribosomal RNA (16S rRNA) amplicon surveys as well as shotgun metagenomics.